Low Neurophysiologic Resistance to Anesthetics as a Marker of Preclinical/Prodromal Alzheimer's Disease and Neurovascular Pathology, Delirium risk and Inattention

Project Summary/Abstract
Delirium is a syndrome of fluctuating changes in alertness and attention that occurs in up to 40% of older
surgical patients (i.e. age >65. Delirium is associated with an increased risk of developing dementia, a
progressive loss of thinking and memory skills that eventually results in an inability to care for oneself and to
live independently. The most common cause of dementia in older Americans is Alzheimer’s disease (AD)
which is associated with a progressive buildup of abnormal deposits in the brain of two proteins, tau and
amyloid beta. Amyloid beta deposits typically develop in the brain for years if not decades before the start of
memory deficits and other AD symptoms. Patients with these early or “pre-clinical” amyloid beta deposits, even
if they appear mentally normal, are often at increased risk of developing delirium after surgery. Here, we will
examine whether these amyloid beta deposits, or other “pre-clinical” changes in brain structure and activity,
predispose patients to show larger than normal brain activity changes in response to anesthetic drugs given
during surgery. The central idea of this proposal is that an altered (or exaggerated) brain activity responses to
anesthetic drugs is a marker of an unhealthy brain, i.e. a brain with signs of “pre-clinical” AD and which is at
increased risk of postoperative delirium. First we will examine whether patients with evidence of brain amyloid
beta pathology (as measured by spinal fluid amyloid beta levels) have altered brain activity responses to
anesthetic drugs. Second, we will use brain imaging to determine whether changes early AD-like changes in
brain structure and connections are associated with altered brain activity responses to anesthetic drugs. Third,
we will determine whether altered brain activity responses to anesthetic drugs are associated with increased
postoperative delirium occurrence and severity. This work will help us understand mechanisms underlying
postoperative delirium and AD and related dementias, and the links between them. Further, this work will
provide a way for anesthesiologists (and surgeons) to use brain activity recording data already in wide use in
American operating rooms to predict which patients are likely to develop postoperative delirium and/or AD,
which could allow these patients to be selected for interventions to prevent these disorders.

Public health relevance
Project Narrative More than 16 million older Americans undergo anesthesia and surgery each year. Up to 40% of these patients develop postoperative delirium, a syndrome of waxing and waning changes in levels of alertness and attention, and which is associated with long term cognitive decline and an increased risk of developing Alzheimer’s disease. In this project, we seek to better understand how early Alzheimer’s disease-type changes predispose patients to show abnormal responses to anesthetic drugs, and the relationship between abnormal brain responses to anesthetic drugs and the risk of postoperative delirium.